AI-accelerated optical simulation for fast timing nuclear imaging

Project Summary/ Abstract
Improving quantification at high spatial resolution is driving technology developments in nuclear imaging.
Positron emission tomography (PET) scanners and single photon emission computed tomography (SPECT)
use radiation detectors, which performance can be improved when the image formation process is
understood. Optimizing optical mechanisms such as scintillation or prompt photon emission at the core of
these detectors is essential to advance the technology and is the focus of this proposal. Due to the complexity
of these phenomena and the difficulty to disentangle their components experimentally, research on radiation
detector optics relies on simulations integrating high and low energy physics. No simulators currently offer
the speed and fidelity necessary to understand image formation from the detector to the system.
We propose to develop a radically different AI-based high-fidelity optical modeling framework,
allowing multidimensional optical information to be rapidly generated, collected, and processed at the system
level. By replacing individual photon tracking with a deep-learning approach, we expect to accelerate
simulations by several orders of magnitude in systems involving extensive optical photon tracking, such as
large detectors or fast timing detectors. We organize this R01 proposal in three specific aims focusing on
implementing this framework in the Geant4/GATE simulators and applying it to time-of-flight (TOF)
PET. GATE is a free opensource platform at the forefront of nuclear medicine simulation. We have a track
record of developing optical modeling strategies and created the LUT Davis model. This grant will design and
implement the optiGAN, a custom generative adversarial network (GAN) that will be trained with high-fidelity
simulations based on the LUT Davis model. New light transport features and crystal-photodetector interface
models mixing particle and wave optics will be developed and integrated into the optiGAN (Aims 1 and 2).
We have extensively studied and developed Cerenkov-based radiation detectors, one of the prompt
photon emission mechanisms most pursued to achieve timing resolution below 50 ps and unlock
reconstruction-free PET. To develop prompt photon-based PET systems several questions must be solved:
how to improve the production and transport of these prompt photons with new materials, how to improve
their collection, and how to harness the prompt photon information for fast coincidence timing. These
questions motivate the development of innovative detector optics and algorithms for TOF PET, which we will
investigate with the optiGAN together with experimental and theoretical work (Aims 2 and 3).
The objective of this grant is to enable a leap in detector technology through unprecedented simulation
capabilities and new strategies to leverage fast detectors in nuclear imaging scanners. Developing detector
technology now that enables the next generation of scanners to respond to clinical and research needs of
nuclear medicine is essential, as the integration of these advances requires years before commercialization.

Public health relevance
Narrative The exploding field of radio-theranostics makes nuclear imaging a central tool and redefines its performance requirements. Nuclear imaging technology is undergoing a paradigm shift focusing on utilizing timing information to enable a leap in image quality. Biomedical researchers need new simulation and experimental tools to develop these fast radiation detectors, which this project proposes to develop and apply with AI-based optical simulation software.